CCC EQUATE (Equitable Quantification And Task Evaluation)

Project Summary/Abstract
Children with medical complexity (CMC) are an extremely vulnerable population with significant morbidity
and mortality risk. To facilitate the study of CMC, Complex Chronic Conditions (CCCs) were defined in 2000
as a set of ICD-9-CM codes specified as “CCCs” with categories (such as neurologic, cardiovascular,
metabolic, and other congenital or genetic defect). Three important concerns regarding the widely used CCC
system motivate this proposal. First, the CCC system is now used “off-label” for different tasks including
adjustment of health status in studies not specifically focused on CMC, and for the identification of children
who might benefit from comprehensive complex care services. Accordingly, the CCC system needs to be
evaluated regarding performance accuracy for various tasks. Second, the CCC system needs to be assessed
for potential embedded associations between ICD codes and patients’ socioeconomic status (which, for
historical reasons, is associated with the structural bias markers of race and ethnicity), arising from
differential access to healthcare and diagnostic testing, as well as genetic conditions related to genetic
ancestry. Embedded associations might bias the aggregated CCC system, affecting the identification of or
adjustment for medical complexity. Third, these two concerns must be considered jointly: the CCC system
might be accurate but, due to any embedded associations, perpetuates disparities. To address these
concerns, we propose the CCC EQUATE (Equitable Quantification And Task Evaluation) project. We will
create scenarios using two data sources, Medicaid claims data and 52 children’s hospitals inpatient data. We
will focus on the representative outcomes of hospitalizations (including readmissions) and mortality
(specifically, inpatient mortality). Specifically, we aim to: Aim 1. Evaluate the performance of the CCC system
across settings for these specific outcomes. Aim 2. Quantify the degree of embedded associations between
ICD codes and patients’ race and ethnicity. Aim 3. Quantify potential perpetuation of bias in CCC system
performance due to embedded associations in ICD codes. In sum, this project will safeguard against the CCC
system having subpar task performance in certain settings for specific outcomes, and from inadvertently
perpetuating bias. Furthermore, the methods and findings will be generalizable to all ICD-code based
classification systems. Ultimately, the project will enhance equity, enable future research, and help improve
care for CMC and their families.

Public health relevance
Project Narrative Children with medical complexity (CMC) are an extremely vulnerable population with significant morbidity and mortality risk, and methods to identify CMC for research or enrollment in clinical programs often rely on diagnostic codes. This proposal is motivated by the premise that the accuracy of these methods warrant more rigorous evaluation, and furthermore due to differences in access to healthcare and diagnostic evaluations for various patient populations, diagnostic codes may reflect broader historical and societal biases and disparities (as preliminary data suggests). We propose to evaluate the accuracy and potential bias of these methods to promote the most effective and equitable care of CMC, and the methods and findings likely will be generalizable to all patient classification systems based on diagnosis codes.